A Trial to Evaluate Renal Artery Denervation in Addition to Catheter Ablation to Eliminate Atrial Fibrillation (ERADICATE-AF II)

ABSTRACT
Pulmonary vein isolation (PVI) is the cornerstone of ablation strategies for atrial fibrillation (AF) and has been
consistently effective in reducing arrhythmia recurrence. Nonetheless, PVI has a recognized and not insignificant
rate of short- and long-term failure, often requires multiple procedures and is less effective for persistent AF. The
mechanisms of AF are diverse, but increased efferent cardiac sympathetic nerve stimulation can contribute to the
development and perpetuation of AF. Reduction in cardiac sympathetic input has been proposed as a logical
adjunctive approach to PVI but its technical application via cardiac ablation has had only mixed or modest results.
The therapeutic objective of reduced cardiac sympathetic stimulation can be potentially accomplished by renal
artery denervation (RDN), a technique originally developed for the treatment of resistant hypertension. RDN’s
potential for antiarrhythmic effect may be mediated by reduced central nervous sympathetic output and is
exemplified by a decrease in whole-body norepinephrine spillover and muscle-sympathetic nerve activity.
The recently completed randomized, multicenter, single-blind clinical trial, ERADICATE-AF, was published in
JAMA and convincingly demonstrated that RDN plus PVI resulted in a relative 43% reduction (absolute change,
15%; P < 0.001) in recurrent incident AF during one year of follow-up. The trial enrolled > 300 patients with
paroxysmal AF referred for ablation, all with poorly controlled hypertension despite medication. There was no
difference in complications between the 2 groups. The trial results suggested that a strategy of reducing cardiac
autonomic input is an effective antiarrhythmic approach. Until now, this approach has only been tested in patients
with resistant and/or poorly controlled hypertension.
We propose a multicenter, single-blinded, randomized clinical trial to Evaluate Renal Artery Denervation In
Addition to Catheter Ablation to Eliminate Atrial Fibrillation (ERADICATE-AF II), to test the hypothesis that RDN
in addition to PVI enhances long-term antiarrhythmic efficacy in comparison to PVI alone for patients with
persistent AF with controlled hypertension or without hypertension. The trial will be advantaged by performing
implantable loop recordings (ILR) in all patients, which will facilitate the calculation of AF burden, now recognized
as a powerful predictor of clinical outcome. With successful completion of this pilot program, we hope to launch
a large-scale trial with cardiovascular and death events as endpoints.
The principal goal of this trial is to determine if adjunctive RDN results in reduced AF burden over time in
comparison to patients who undergo only PVI. The secondary goals are to examine: procedural complication,
postural blood pressure, and pressure control as assessed by 24-hour ambulatory monitors; autonomic nervous
system effects; frequency of cardiovascular hospitalizations; return to persistent AF; need for repeat ablation
procedures; and quality of life.

Public health relevance
Narrative Summary Pulmonary vein isolation (PVI) is the cornerstone of ablation for atrial fibrillation (AF). Increased cardiac sympathetic stimulation can facilitate AF and reduction can be accomplished by renal artery denervation (RDN). The recently completed randomized trial, ERADICATE-AF, convincingly demonstrated that RDN plus PVI resulted in a reduction in recurrent incident AF for uncontrolled hypertensives. We propose a randomized controlled pilot trial, “To Evaluate Renal Artery Denervation in Addition to Catheter Ablation to Eliminate Atrial Fibrillation” (ERADICATE-AF II) to test if RDN plus PVI enhances long- term efficacy vs PVI for persistent AF patients with controlled or without hypertension using implantable loop recordings.